Incorporating mobile technology into postoperative care: a shift in paradigm toward ambulatory surgery in Uganda

TITLE: Incorporating mobile technology into postoperative care: a shift in paradigm toward ambulatory
surgery in LMIC.
PROJECT SUMMARY
In many low- and middle-income countries (LMICs), low-acuity surgeries require postoperative hospitalization
for several days, partly due to concerns of inadequate follow-up after discharge and partly to cultural norms.
This not only poses increased risks of hospital acquired complications, but also increases the total surgical
costs for both patients and facilities. Consequently, this inefficient practice contributes to the barriers to access
safe and affordable surgical care.
We propose an alternate approach of mHealth Ambulatory Surgery with Follow-up Nurse (mAS-FUN), which
does not require patient hospitalization after surgery. Since 2020, we have implemented mAS-FUN at the
Kyabirwa Surgical Center (KSC), the first ambulatory surgery center in rural Uganda. The current proposal
aims to show mAS-FUN is safe, effective, and markedly reduces costs when patient follow-ups can be reliably
performed at home via a cloud-based mobile app and visiting nurse. Based on our robust preliminary data, our
central hypothesis is that implementation of mAS-FUN reduces hospital and patient costs, improves patient
follow-up, and reduces recovery time, without increasing complications, compared to the current inpatient
practice in other surgical facilities across Uganda.
In our preliminary work, we have established the framework for mAS-FUN at KSC, including hiring key
personnel and testing study protocols. In the R21 phase, we will perform a prospective, observational clinical
study aimed at validating the safety, feasibility, acceptability of mAS-FUN for the primary outcomes of costs
for both patients and facilities, whether patients can be assessed after discharged home, and total duration of
postoperative medical care received; and the secondary outcomes of postoperative complications, time to
functional recovery and ability to return to work, and acceptability of mAS-FUN by patients, healthcare
personnel, and the community, as compared to historical controls. Armed with strong partnerships and
adequate preparation during the R21 phase, we will then perform a stratified cluster randomized, controlled
clinical trial during the R33 phase, comparing the novel mAS-FUN versus traditional approaches at
three surgical centers in Uganda.
Demonstrating the feasibility, acceptability, and effectiveness of this novel approach for surgical care – and its
ability to improve outcomes – is necessary for wide-spread adoption. We expect our findings will ultimately shift
the paradigm of how surgery for low-acuity procedures is practiced in Uganda and serve as a model for other
LMICs.

Public health relevance
PROJECT NARRATIVE Surgeries in high-income countries have progressively transitioned to ambulatory settings, but in low- and middle-income countries, even patients who have low-acuity surgeries still typically stay in the hospital after their surgeries, and these postoperative inpatient stays are costly and inefficient, for both patients and the surgical facilities. We propose an innovative approach of mAS-FUN in Uganda, incorporating mobile technology into postoperative care, to ensure safe, cost-effective and efficient care with same-day discharge and reliable follow-up after surgery. Using a multicenter, randomized controlled trial, we will provide the evidence necessary to shift practice towards ambulatory surgery for low-acuity surgical procedures, resulting in more efficient and effective allocation of healthcare resources in LMICs.